Physician Networks for Diabetic Lower Extremity Wounds

Summary/Abstract
Diabetic lower extremity (DLE) wounds affect up to 34% of adults with diabetes and are associated with
substantial clinical morbidity/mortality, increased healthcare utilization, and higher cost of care. However,
persistent racial/ethnic and socioeconomic disparities among DLE wounds remain poorly addressed, and little
is known about the utilization of physician services and role of physician networks in observed disparities. This
proposal responds to PAR-20-310, Health Services Research on Minority Health and Health Disparities, by
conducting a national evaluation of racial/ethnic and socioeconomic disparities in healthcare utilization among
patients with DLE wounds, and assessing the role that physician networks and referral patterns play in
observed disparities. Through the RAND AHRQ U19 Center of Excellence on Health System Performance, our
study will leverage several Medicare data sources, unique physician-level preliminary data, and innovative
methods to improve beneficiary classification of race/ethnicity. The study will focus on Medicare fee-for-service
beneficiaries aged 65 years and older with a new DLE wound and track longitudinal utilization of healthcare
services across multiple clinical settings during the 6-month period following initial wound diagnosis. In Aim 1,
we will use multivariable regression techniques to evaluate racial/ethnic and socioeconomic disparities in
healthcare utilization after initial DLE wound diagnosis. Then, we will map and characterize physician networks
and referral patterns for DLE wounds and examine the effects of network/referral pattern characteristics on
healthcare utilization disparities (Aim 2). Finally, in Aim 3, we will simulate changes to network/referral pattern
characteristics and identify which characteristics have stronger disparity reducing effects, and therefore, are
amenable to intervention development. The proposed study will identify potentially modifiable aspects of
physician networks and referral patterns that contribute to observed disparities in DLE wound care. Results will
inform how policy regarding physician network adequacy, health system organization, and payer incentives
can improve quality of care for patients with DLE wounds and reduce disparities in healthcare utilization. The
project team consists of multiple NIH funded researchers with ample expertise in health disparities research,
network analysis of claims data, statistical methods, and knowledge of clinical context.

Public health relevance
Project Narrative Racial/ethnic and socioeconomic disparities among patients with diabetic lower extremity (DLE) wounds are well documented; however, strategies to effectively close this gap are limited by the lack of robust national data evaluating physician and health system level factors. The proposed study will use comprehensive national data that includes information about patients, physicians, health systems, and geographic location to determine the impact of physician networks and referral patterns on disparities among older adults with DLE wounds. This research has the potential to offer novel approaches to studying physician networks for older adults with conditions, as well as provide a strong evidence base for developing disparity-reducing interventions and policy for DLE wounds.